The role of NPY in stress-induced hematopoiesis

ABSTRACT
Hematopoietic stem cell (HSC) transplantation is a therapeutic cure for hematological malignancies, metabolic
disorders, and inherited and acquired bone marrow (BM) failure. However, myeloablative conditioning regimens
routinely used for transplantation cause acute and long-term BM damage, leading to impaired blood and immune
cell production, often causing fatal consequences. Although myeloablative irradiation/chemotherapy-induced
defects in the BM microenvironment/niche have been reported, the underlying mechanism(s) are not well
understood. The other crucial limiting factor for HSC transplantation is an inadequate number/quality of
transplantable HSPC collected from patients or donors. Emerging evidence suggests the pivotal role of neuronal
signals in the BM niche and HSC function. Peripheral neuropathy is a common complication associated with
radiotherapy and chemotherapy. Thus, a deficit of neuronal signals in the BM can impair hematopoietic
reconstitution. We recently reported that neuropeptide Y (NPY), one of the most abundant neurotransmitters,
regulates hematopoietic stem and progenitor cell (HSPC) release into circulation by regulating BM vascular
gateway function. Preliminary data showed that steady-state, NPY knockout (KO) mice have fewer HSPC and
BM niche endothelial cell (EC) and mesenchymal stromal cell (MSC) than wild-type (WT) mice. Interestingly,
total body irradiation (TBI) reduces NPY levels in mouse BM, accompanied by a scarcity of EC and MSC.
Furthermore, we found that BM EC and MSC from NPY KO mice produce higher reactive oxygen species (ROS)
than WT mice. Also, NPY supplementation enhances HSPC ex vivo expansion. Based on these observations,
we hypothesize that NPY is required for BM niche regulation and HSPC homeostasis, and cytotoxic stress-
induced deficit of NPY signals in the BM impairs NPY-regulated BM niche extrinsic and HSPC intrinsic
mechanisms leading to hematopoietic dysfunction. This hypothesis will be tested in three aims herein:
Specific aim 1 will investigate whether myeloablative irradiation-mediated deficit of NPY signals in the BM
causes acute and chronic defects in the BM niche and impairs hematopoietic regeneration. Using mouse HSC
transplantation models, we will evaluate the relationship between NPY signals and irradiation-induced structural
and functional defects in the BM niche and HSPC.
Specific aim 2 will identify the mechanism(s) via which NPY signals promote BM niche restoration and
hematopoietic regeneration. We will use molecular and functional analysis to explore how NPY signals control
oxidative stress and vascular integrity in the BM niche constituents.
Specific aim 3 will investigate whether NPY supplementation during ex vivo HSPC expansion can improve
hematopoietic engraftment after transplantation.
The proposed studies will shed new light on how stress-induced neuropathy contributes to stem cell niche
damage and blood stem cell defects and identify a potential therapeutic target to improve HSC transplantation.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cell (HSC) transplantation is a potential cure for several malignant and non-malignant blood disorders. However, delayed/impaired hematopoietic reconstitution due to myeloablative conditioning induced bone marrow damage, and limited availability of donor HSC often causes fatal complications. This project seeks to understand how myeloablative stress-induced alternation of NPY signals in the bone marrow contributes to hematopoietic defects after transplantation, and whether modulating NPY signaling can improve HSC transplantation efficacy.